Non-racemic metabolic biomaterials for HFpEF

Heart failure with preserved ejection fraction (НFpEF) is a syndrome that manifests in approximately 50% of all
heart failure patients. The incidence and prevalence of НFpEF is sharply rising in the last years, however most
patients remain unaddressed. One of the main reasons is the lack of efficacy of drugs, but the other is that
historically HFpEF patients were excluded from many heart failure clinical trials. As a result, current treatment
guidelines exist for other heart failure types, but completely lack for HFpEF.
This proposal will develop a new class of biomaterial-based immunomodulators which work via targeted
modulation of specific immune cells in HFpEF. These cells, namely monocytes and T-lymphocytes, are known
to be responsible for HFpEF pathogenesis and their targeting is hypothesized to delay the onset of HFpEF
and, possibly, alleviate its common consequence - cardiac fibrosis.
We propose to develop such biomaterials and test them in mouse models of HFpEF through consecutive
execution of the following Specific Aims: 1) We will synthesize and test these polymeric materials with the goal
of developing lead formulations that will effectively tune activation of the immune cells in vitro; 2) We will test
lead formulations in in vivo models of immune cell activation and further optimize our lead formulations; 3) We
will thoroughly investigate best-performing materials in clinically-relevant mouse models of HFpEF. In addition,
we will thoroughly investigate safety, including evaluation of systemic immunosuppression of these materials.
Therefore, this proposal is significant, because targeting inflammatory and immune pathways proposed here
could provide a promising approach for developing therapeutic options in HFpEF patients who have not yet
responded adequately to approved and late-stage investigational treatments.

Public health relevance
Relevance to Public Health Patients suffering from heart failure with preserved ejection fraction remain unaddressed because treatment options are lacking. This grant develops an entire new class of metabolic therapies aimed to target heart failure with preserved ejection fraction through engineered biomaterials and their interaction with immune cells shown to have important implications in this devastating disease.